Utilization of MoTrPAC data to characterize white adipose tissue molecular aging and its potential mitigation with endurance training-from a sex-specific perspective

ABSTRACT - Pacific Northwest National Laboratory – PNNL
The pathogenesis, presentation and risk of cardiometabolic risk factors and diseases differs by sex. The
subcutaneous white adipose tissue (scWAT) is a dynamic storage and endocrine organ with central roles in
mediating cardiometabolic disease risk throughout the lifespan. As we and others previously demonstrated, the
scWAT of adult female rodents and humans displays a metabolically healthy and cardioprotective phenotype
relative to that of males. However, declines in female sex hormones that occur with age shift scWAT phenotypes
to more closely resemble that of males and drive age-associated increases in cardiometabolic disease risk.
Regular endurance exercise training (EET) substantially reduces cardiometabolic disease and all-cause
mortality risk throughout the lifespan, yet the systemic molecular mechanisms of the health benefits of EET
warrant additional investigation, especially in terms of sex and age-associated differences. The Molecular
Transducers of Physical Activity Consortium (MoTrPAC) seeks to develop a molecular map of exercise to better
understand the role of exercise on health and disease. Here we propose to utilize both publicly and privately
available data from MoTrPAC to uncover molecular features of scWAT aging and the impact of EET on scWAT
molecular aging features in males and females. This proposal seeks to address the following: Aim 1) define
scWAT molecular aging including the impact of sex on scWAT molecular aging phenotypes in the sedentary
state; 2) determine the impact of age and sex on the scWAT response to EET. We will accomplish this by first
comparing differences in the scWAT molecular landscape of sedentary 6 mo F344 rats (MoTrPAC publicly
available data set) to 18 mo F344 rats (MoTrPAC currently privately available data set) (Aim 1A). Then we will
examine correlations between scWAT sample-level multiomic features and the age of sedentary human
participants separately by sex to identify age-associated molecular features shared between human and rat (Aim
1B). We will then compare differences in the multiomic response to EET by comparing feature level and pathway
enrichments responses in 6 and 18 mo male and female rats (Aim 2). Comparison of scWAT sexual dimorphism
and the dynamic response to exercise training by sex and age through utilization of multiomic data sets
generated by MoTrPAC offers unprecedented potential to understand scWAT molecular aging and its
association with disease-associate phenotypes—all data and analyses will be made publicly available to facilitate
dissemination to the scientific community. Findings thus offer the potential to elucidate molecular drivers of
sexual dimorphism in scWAT aging biology and inform future studies towards a precision medicine approach.

Public health relevance
NARRATIVE - Pacific Northwest National Laboratory – PNNL Substantial sex differences in cardiometabolic disease pathogenesis, risk and outcomes exist throughout the lifespan. Subcutaneous white adipose tissue (scWAT) dysfunction in obese and sedentary states promotes age- associated cardiometabolic disease risk, yet sex-specific changes in the scWAT molecular landscape that occur with aging and the ability of endurance exercise to mitigate scWAT molecular aging has not been thoroughly investigated, especially from a sex-specific perspective. Here, we propose to utilize publicly available and privately-held data from MoTrPAC (multiomic rat training in adult and aged animals and sedentary humans) to characterize sex differences in the scWAT that occur with age (rats and humans) and the effect of age and sex on the scWAT molecular responses to endurance training (rats).